From friend to foe: proviral role of IRF-3 in chronic gammaherpesvirus infection

Abstract
Gammaherpesviruses establish life-long infections in >95% of adults worldwide and are
associated with B cell lymphomas. Gammaherpesvirus-driven cancers develop in both
immunocompromised and immunocompetent individuals; prevention of such cancers is
currently impossible due to absence of vaccines, curative antivirals, and defined risk factors for
lymphomagenesis. Manipulation of B cell differentiation lies at the heart of chronic
gammaherpesvirus infection and pathogenesis. Specifically, gammaherpesviruses use natural
proliferative capacity of germinal center B cells to amplify latent viral reservoir. Further,
germinal center B cells are believed to be the target of viral transformation, as a majority of
gammaherpesvirus-driven B cell lymphomas are germinal center-derived. Despite the
importance of germinal center response for chronic infection and lymphomagenesis, very few
factors that control infection of germinal center B cells have been defined. Interferon Regulatory
Factor 3 (IRF-3) is a transcription factor that targets many cellular genes, including interferon
(IFN) β. We discovered that, contrary to the predicted role of IRF-3 as an antiviral factor, IRF-3
supports latent gammaherpesvirus infection of germinal center B cells. The proposed studies
test the hypothesis that IRF-3 is usurped by gammaherpesvirus to facilitate latent infection of
germinal center B cells, with subsequent generation of memory B cells that host life-long latent
viral reservoir. This is achieved through IRF-3-dependent regulation of cellular and viral target
genes. Successful completion of the proposed studies will offer an insight into the mechanism
by which the virus usurps a classical innate antiviral factor for the viral benefit.

Public health relevance
Narrative: Over 95% of adults are infected with gammaherpesviruses that are known to drive development of B cell lymphomas. Unfortunately, very little is known about the viral and host factors that influence the development of gammaherpesvirus-driven lymphomas. This proposal will determine how a classical antiviral factor of the host is usurped by gammaherpesviruses to establish life-long infection.